B: Developmental

Project Summary/Abstract
The UW/Fred Hutch CFAR Developmental Core (DC) focuses on growing the next generation of HIV
researchers. During the past 5-year award cycle, our CFAR DC doubled funding for the DC which enabled
support for more new investigators than in any previous cycle. Our program has continued to have an
extraordinarily high return on investment (1106% for DC New Investigator Awardees from 2011-2021). For the
next 5-year cycle of the DC, we prioritize research that integrates community engagement and EDI. Throughout
our activities, we aim to strengthen bi-directional engagement with our community of people living with and at
risk for HIV and to expand the diversity of lived experiences represented by CFAR investigators.
Aim 1. To cultivate and nurture a robust cadre of interdisciplinary HIV/AIDS researchers by providing
structured mentoring and research support to early-stage investigators and investigators new to HIV
research who are affiliated with the UW/Fred Hutch CFAR. 1) Offer New Investigator Awards (NIAs); 2)
Provide Mentored International Investigator Awards (MIIAs); 3) Collaborate with the Office of Community
Engagement (OCE) to offer a Community Investigator Award Program (CIAP); 4) Provide International Pilot
Awards (IPAs); 5) Provide International Infrastructure Awards (IIAs); 6) Support NIH Diversity and other NIH
Supplements; 7) Offer Trainee Support Grants (TSGs); 8) Facilitate Early-Stage Investigator Group (ESIG); 9)
Incorporate input from the CFAR Equity, Diversity and inclusion (EDI) Director.
Aim 2. To enhance skills of HIV investigators at CFAR-affiliated institutions through training on grant
and manuscript writing, development of opinion pieces, and research skills; through opportunities for
dissemination and feedback; and to foster communication between CFAR investigators and community
members through enhanced collaborations. 1) Provide trainings on manuscript and grant writing in Seattle,
Kenya, Uganda, and Peru; 2) Leverage existing UW research training opportunities on behalf of CFAR members
and community-based collaborators; 3) Offer Mock Study Section; 4) Hold annual research symposium; 5)
Collaborate with the OCE to offer a Community Engagement Academy; 6) Include Community Consultative
Liaison input on strategic planning.
Aim 3. To advance and sustain skills of CFAR-affiliated mentors across the lifespan (senior, mid-career,
early) and provide supplemental mentoring assistance when needed. To improve mentoring skills and
mentor-mentee relationships, particularly to enhance mentorship of BIPOC trainees. 1) Conduct an annual
mentor-the-mentor workshop; 2) Collaborate with the UCSF CFAR to share mentoring resources including co-
leadership for selected activities in the new UCSF-led inter-CFAR working group to support mentorship of URM;
3) Assist in matching ESI to mentors and navigating challenging situations.
These aims will amplify our impact by advancing a diverse, vibrant cadre of HIV investigators.